Improving the interaction of hematopoietic stem cells with the perivascular niche to promote engraftment

PROJECT SUMMARY/ABSTRACT
Hematopoietic stem and progenitor cell (HSPC) transplantation is a curative treatment for many blood diseases
and cancers. However, these procedures still need to be optimized to improve patient outcomes and survival.
HSPCs reside in a microenvironment surrounded by niche cells that help regulate their function. Our research
proposal seeks to address fundamental questions regarding the cellular interactions between HSPCs and niche
cells. During development in the embryo, HSPCs move through different tissues and have changing
requirements for contact with the microenvironment. HSPCs first arise in the dorsal aorta, a large vessel in the
embryo, and are then released into circulation. Next, HSPCs migrate to the fetal liver where the population of
cells expands exponentially via symmetric divisions. Finally, HSPCs migrate again to colonize the bone marrow
where they will remain throughout adulthood. As HSPCs are migrating between these different hematopoietic
tissues, they are also becoming more mature and are programmed towards their adult quiescent state. We use
zebrafish and mice as model systems that are highly conserved with humans and have many genetic tools for
functional testing and live imaging of cellular behaviors. In zebrafish, we have found a novel role for vascular
endothelial growth factor c (vegfc) in the release of HSPCs from the dorsal aorta. Vegfc also regulates a fate
decision in pre-HSPCs that determines if they will become a stem cell or a different type of progenitor cell. At
later stages, we found a programming function for integrin alpha 4 (itga4) in the caudal hematopoietic tissue
(CHT), the zebrafish equivalent of the fetal liver. We hypothesize that the timing of HSPC contact and transitions
between developmental niches is critical for their correct programming. We will address this hypothesis through
the following Specific Aims: 1) Define the role of vegfc in HSPC transition and release from the dorsal
aorta. 2) Determine how itga4-dependent contact with the CHT niche programs HSPCs as they transition
from fetal-like to adult stages. We will perform in vivo genetic knockdown and small molecule treatments,
together with live imaging, to understand the dynamic interactions between HSPCs and niche cells. We will then
translate these results to an in vitro vascular niche that is used to differentiate cells into transplantable HSPCs
that could lead to cell-based therapies for patients.

Public health relevance
PROJECT NARRATIVE Blood stem cells live in a complex microenvironment or “niche” in the bone marrow and are supported by many different types of cells. We want to understand how blood stem cells interact with niche cells when they are developing in the embryo and in adulthood. We believe defining these cellular interactions will improve our ability to make blood stem cells in the lab, and to improve outcomes for patients who receive blood stem cell transplants.